Leveraging human iPSC technology to understand the role of neuroinflammation in 22q11.2 deletion syndrome

PROJECT SUMMARY
Chromosome 22q11.2 deletion syndrome (22qDS) is a rare genetic disorder caused by microdeletions of 1-3
MB on chromosome 22 leading to haploinsufficiency of ~50 protein-coding genes and numerous non-coding
genes. Genes in the 22q11.2 region encompass a variety of functions, including miRNA processing,
mitochondrial metabolism, and protein trafficking which shape cellular function through distinct pathways. At the
clinical level, 22qDS manifests in cardiovascular, immune, and nervous system defects. Strikingly, ~25 % of
22qDS patients develop schizophrenia (SCZ) with clinical symptoms mirroring idiopathic SCZ. In particular, while
several lines of evidence show that inflammation and microglial hyperactivation contribute to SCZ development
through overt synaptic pruning during adolescence and idiopathic SCZ patients display chronic peripheral low-
grade inflammation and microglial activation, 22qDS patients also show signs of dysregulated immune
homeostasis with elevated plasma pro-inflammatory cytokine levels, particularly in individuals with psychosis.
Microglia are brain residing immune cells that play the central role in brain development and inflammation.
However, how microglial functions are impaired in 22qDS and how their dysfunction contributes to 22qDS-
associated neuropsychiatric disorders remain elusive. In this study, we will comprehensively assess the impact
of 22qDS on microglial function by using 22qDS patient-specific induced pluripotent stem cell (iPSC) models.
We have successfully generated iPSCs from a cohort of 22qDS patients with age- and sex-matched controls
(HC) and differentiated them into microglia (iMG). Our preliminary data suggest that 22qDS iMG have
dysregulated mitochondrial metabolism, reduced ribosome biogenesis and display an exacerbated response to
inflammatory stimulation. We hypothesize that diminished expression of genes located on 22q11.2 leads to
microglial hyperactivation, partially through the miRNA dysregulation, leading to impaired neurodevelopmental
and neuronal dysfunction. We will comprehensively assess the impact of 22qDS on microglial function. We will
determine the molecular and cellular impacts of 22q11.2 deletions on microglia functionality and mechanistically
interrogate the function of individual 22qDS genes (Aim 1). We will also assess the role of miRNA dysregulation
in 22qDS microglia (Aim 2). We will further determine the impacts of 22qDS iMG on neuronal development and
function by using microglia-integrated cortical organoids (Aim 3). The proposed experiments will provide
important insights into the role of neuroinflammation in 22qDS and lead to identification of potential therapeutic
targets that likely can inform on idiopathic SCZ as well.

Public health relevance
PROJECT NARRATIVE The current proposal will leverage human induced pluripotent stem cell technology to determine the cellular and molecular impacts of 22q11.2 deletion, one of the strongest genetic risk factors for schizophrenia, on microglial function. While several lines of evidence show that inflammation and microglial hyperactivation contribute to schizophrenia development, how microglial functions are impaired in 22q11.2 deletion syndrome (22qDS) and how their dysfunction contributes to 22qDS-associated neuropsychiatric disorders remain elusive. The proposed experiments will significantly advance our understanding the role of neuroinflammation in 22qDS and lead to identification of potential therapeutic targets that likely can inform on idiopathic schizophrenia as well.